Cracking the Microbial Language: Characterization of Novel Biocatalysts for Interfering with Signaling to Illuminate Quorum Sensing Mechanisms

PROJECT SUMMARY / ABSTRACT
Bacteria are important to human health and therefore, effective control strategies are critical to
mitigate the risks posed by microbial activities. The current paradigm of chemical (antibiotics) control
is eroding with the escalating challenge from resistance, and new strategies are needed. Quorum
sensing (QS), a communication system utilized by bacteria and based on signaling molecules is
appealing because it controls several bacterial behaviors. However, our current understanding of QS
and our ability to manipulate is rudimentary.
Here we propose to comprehensively investigate QS using interference strategies, specifically
enzymes such as lactonases that can degrade the signaling molecules N-acyl-homoserine lactones, to
decode the microbial language. Our group demonstrated the efficacy of interference in QS using these
enzymes across various contexts, including monocultures and complex communities. Yet, challenges
remain in achieving the selectivity needed to specifically isolate the contribution of individual signals
and infer their biological roles. We propose to address critical gaps in QS interference by elucidating
its effects on bacterial behavior and interspecies competition. Additionally, we will continue to unravel
the molecular determinants governing lactonase mechanisms and substrate selectivity. Lastly, we will
characterize and enhance enzymes capable of degrading orthogonal signals, such as autoinducing
peptides (AIPs) to considerably expanding the scope of QS manipulation.
The expected impact from this proposal extends beyond the fundamental insights into bacterial
communication. By unveiling novel regulatory mechanisms and advancing our enzymatic
understanding, this work will enable the design of highly specific quorum quenchers. Ultimately, these
findings will inform bacterial control strategies with implications for human health and beyond.

Public health relevance
PROJECT NARRATIVE Quorum sensing, a bacterial communication system, is a major contributor to bacterial interactions, yet its biological functions and mechanisms are still largely unknown. We propose to design specific communication quenchers via detailed structural studies and to decode this chemical language through enzyme interference. Cracking this code will pave the way for novel, transformative bacterial control solutions with critical implications for human health and beyond.